Shared Resource Management

SHARED RESOURCE MANAGEMENT (SRM)
PROJECT SUMMARY/ABSTRACT
The eight Shared Resources (SRs) plus one developing SR are critical to the research mission of the UC
Davis Comprehensive Cancer Center (UCDCCC). The SRs provide members access to technologies,
services, and experimental planning advice and consultation that enhance research interactions and
productivity, facilitate cancer-related research activity, and enable cost-effective and efficient operations.
Specifically, the SRs offer cancer researchers centralized access to specialized scientific expertise,
infrastructure and equipment, robust technologies, advanced instrumentation, and subsidized services. To
enable the SRs to fulfill these roles and expectations, the UCDCCC administration centralizes SR
management, supports, and coordinates SR activities, and provides essential operational infrastructure and
business processes. The UCDCCC administration manages the SRs and establishes appropriate policies
governing their use, including assuring accessibility to members across the Sacramento and Davis campuses;
monitoring the quality of the SRs; determining current and future scientific needs of UCDCCC members;
determining future plans for SRs, including those in development; ensuring sound financial support for SRs;
and interacting with the main campus in the planning, oversight, and coordination of institutional cores,
services, and other campus resource and service cores. Operational oversight is provided by the AD for SRs
KC Kent Lloyd, DVM, PhD, who supervises and supports fiscal management, evaluation and assessment
tools, outreach and marketing mechanisms, strategies to maximize utilization and functional efficiency of the
SRs, and the development of new SRs. Since the last competitive renewal, significant improvements have
been made and new processes and mechanisms implemented that optimize centralized oversight,
coordination, and operational efficiency of all SRs. For example, members with peer-reviewed, funded projects,
have prioritized and/or subsidized access to SRs compared to all other users. Fees charged to members using
SRs for cancer-related research are subsidized to a varying extent (generally 13-30%), depending on the type
of service and on each SRs budget. In some cases (e.g., biostatistics), the SR does not direct charge users but
instead uses non-CCSG funds for salary support to render services to UCDCCC members. To facilitate these
and other activities, centralized SRM’s Specific Aims are to: 1) Meet the scientific needs of UCDCCC members
through centralized management of high-quality SRs. 2) Assist with the promotion of research collaborations to
increase scientific impact of the UCDCCC. 3) Provide business support for the SRs by establishing appropriate
policies, business practices, operational processes, and infrastructure governing their use and accessibility to
UCDCCC members. 4) Establish common processes to determine and respond to current and future scientific
needs of SR users.